Understanding the clinical impact of cumulative genetic risk to glaucoma

Primary open-angle glaucoma (POAG), the most common glaucoma subtype, is a prototypical common
complex disease with a strong polygenetic component. This proposal is aligned with the NIH roadmap,
leveraging the decade-long effort of gene discovery for POAG into precision medicine approaches that
facilitate an early glaucoma diagnosis while outlining strategies to prevent glaucoma-related blindness. In this
study, we propose 3 specific aims. 1) We will assemble all of the common gene variants discovered for POAG
over the past decade into a multi-ancestry panel to test whether they predict glaucoma in 4 independent study
populations (the UK Biobank, a health professional case-control study embedded in a population based
sample, and patients from 2 hospital-based biobanks (total sample size: over 12,000 POAG cases in ~600,286
subjects). 2) Hospital-based biobanks offer an opportunity to contributed precision based medical knowledge
about glaucoma. We will invite 800 patients from two hospital-based biobanks with low and high glaucoma
polygenetic risk score (PRS) for systematic clinical evaluation. This detailed phenotype-genotype correlation
will provide unique insights into glaucoma and will demonstrate the utility of such biobanks to identify
previously undiagnosed disease, an unmet need in the field of glaucoma. 3) While a glaucoma PRS is
probably the strongest predictor of glaucoma, we anticipate that a considerable number of subjects with high
PRS will not demonstrate glaucomatous disease; conversely, some subjects with low PRS will have glaucoma.
We will explore whether genetic variants such as MYOC Q368X and unique environmental factors (dietary
nitrate intake from vegetable sources, estrogen exposure duration in women and dental health status) modify
the relation between our PRS and glaucoma in our 4 study populations. By formulating and applying a multi-
ancestral glaucoma PRS to an ethnically-diverse group of subjects, this proposal will highlight the role of a
glaucoma genetic informativity panel as a screening tool. This proposal will advance the major objective of
promoting POAG to the status of a precision-based medicine discipline. Finally, it will identify specific disease
prevention strategies that could be implemented before a diagnosis is made.

Public health relevance
Primary open-angle glaucoma (POAG) is an intraocular pressure-related chronic optic nerve disease that produces characteristic visual loss patterns. In this proposal we will study the clinical impact of cumulative common genetic variants in relation to this disease. Overall this work will help translate gene discovery efforts into precision medicine approaches for the diagnosis, prevention and treatment of POAG.